Comprehensive Cancer Center Support Grant

ABSTRACT – DIRECTORS OVERVIEW
The O’Neal Comprehensive Cancer Center (O’Neal) at the University of Alabama at Birmingham is the only NCI-
Designated Cancer Center in a four-state region including Alabama, Mississippi, Louisiana, and Arkansas.
O’Neal’s catchment area is the State of Alabama, the state with the 8th highest cancer mortality in the country
and a state with significant racial disparities in cancer incidence and mortality. More than half of the population
is medically underserved, and 16 of the 67 Alabama counties are rural (RUCC 7-9). O’Neal (originally the UAB
Comprehensive Cancer Center) was one of the first eight cancer centers designated by the NCI nearly five
decades ago. O’Neal’s vision is Life without cancer. Our mission is to advance our understanding of cancer to
improve prevention, detection, treatment, and survivorship for all people. A matrix Cancer Center, O’Neal has
187 members across 7 UAB Schools and 28 Departments. O’Neal members are supported by $22M of direct
cost funding from the NCI and $59M in total direct cost cancer-relevant funding. Their research productivity led
to 2,390 publications in the current CCSG cycle. O’Neal members are organized into 4 Research Programs:
Cancer Biology and Immunology (CBI), Experimental Therapeutics (ET), Neuro-Oncology (NO), and Cancer
Control and Population Science (CCPS). Program research is supported by 12 Shared Resources and is
connected to 15 Disease Working Groups (DWGs) focused on translational clinical research and 8 Cancer
Management Teams (CMTs) of the O’Neal Cancer Service Line (CSL) focused on multi-disciplinary cancer care.
Programmatic Research is focused on seven cancers identified by the Office of Community Outreach and
Engagement (COE) as being significant burdens to our catchment area communities. These include breast,
colon, prostate, brain, lung, and cervical cancers, as well as multiple myeloma. COE provides cancer prevention,
screening, and care education in most Alabama counties with a focus on the 26 counties with the greatest cancer
burdens. During the current CCSG cycle, O’Neal members made significant contributions to our understanding
of cancer that impacted treatment, including new approaches for treating brain cancers. In addition,
improvements in O’Neal clinical trials processes and support lead to a 14% increase in accruals to therapeutic
trials in 2020 over 2019 despite COVID-19, and a projected 21% increase in 2021. In addition, there was a 29%
increase in NCI funding including two newly awarded NCI P01s, a $30M naming gift from O’Neal Industries, and
initiation of a $300M project to build a new free-standing cancer hospital on the UAB Campus. Completion of the
2021-2026 O’Neal Strategic Plan revealed areas of basic, translational, and clinical excellence, including
metabolism and obesity in cancer, cancer imaging, cancer immunology, cancer survivorship and increases in
cancer care access to the underserved. This sets the stage for impactful science in the next CCSG cycle that
will further diminish the cancer burdens and disparities in the State of Alabama.

Public health relevance
PROJECT NARRATIVE – DIRECTORS OVERVIEW The O'Neal Comprehensive Cancer Center is committed to reducing the cancer burdens and cancer disparities in the State of Alabama. This is done through a basic science and population science strategic research plan that is developed with community engagement and focused on elucidating the risk factors and mechanistic underpinnings of these cancer burdens and cancer disparities. The results of this work are then translated through diagnostic and therapeutic clinical trials to impact cancer outcomes and behavioral interventions to mitigate cancer risks and improve the quality of life of cancer survivors in our catchment area.